Bioactivity Of Opioidmimetic Substances

Summary of Work: Antinociception and antagonists to this activity by recently developed opioidmimetic substances was determined in vivo in mice in comparison to morphine (mu-opioid receptor agonist) and deltorpin (delta agonist) to assess their mode of action. The antinociception profile paralleled that of the in vitro functional pharmacological data [GPI (guinea-pig ileum) and MVD (mouse vas deferens)] and reflected the opioid-receptor binding affinity (see, Project 1 for details on the interaction of compounds with delta- and mu-opioid receptors). A series of novel bis-Dmt-Tic-containing alkyl and Dmt-alkyl pyrazinone group as opioidmimetic compounds exhibited antagonism in vitro and in vivo using the hot-plate test which measures supraspinal effects (central nervous system). The control compounds, 3,6-bis-[Dmt-NH-(CH2)n]-2(1H)-pyrazinone compounds, in contrast exhibited central (CNS) mediated analgesia and wereorally bioavailable opioidmimetics. Interestingly, the N,N-dimethyl-Dmt-Tic-NH-adamantane and -tert-butyl derivatives inhibited tolerance to morphine in mice, which suggests that the multidrug resistance P-glycoprotein 1 was involved in this observation due to the inhibition in vitro of Pg-1 by these opioid analogues.[unreadable] [unreadable] Studies on the mu opioid agonists containing Dmt in lieu of Tyr in endomorphins-1 and -2 revealed differences in their mode of action that also serve to differential these stucturally related compounds. Whereas both compounds exhibited potent analgesia, their mode of action and degree of analgesia was significantly different. Dmt enhanced all measured parameters of activity by orders of magnitude both in vitro and in vivo. The N-allyl derivatives of both endomorphines were potent mu-opioid antagonists as demonstrated by intracerebroventricular administration in mice: they effectively inhibited morphine antinociception similar to naloxone.